B Vitamins and One-Carbon Metabolism in Health and Disease

PROJECT SUMMARY/ABSTRACT
Our R13 application aims to obtain partial funding for the “B-vitamins and One-Carbon Metabolism in Health and
Disease” conference set to convene August 11-16, 2024, in Niagara Falls, NY. The meeting is part of the
Federation of American Societies for Experimental Biology (FASEB) Science Research Conference (SRC) series
and convened every 2 years since its inception in 1986, celebrating its 40-th anniversary/20th meeting in 2024.
The idea under it is to assemble basic scientists, clinicians, epidemiologists, and public health experts to present
and discuss the latest research in B-vitamins and one-carbon metabolism (OCM). It brings together the most
prominent experts in the field from all-over the world and the promising young scientists, both students and
postdocs. Specific Aims of the conference are: 1) Assemble the world experts and trainees working in areas of
B-vitamins and OCM, to present, analyze and discuss the most recent, cutting-edge research, with special focus
on unpublished studies; 2) Provide opportunities for students, trainees and investigators that are new to this
meeting to present and discuss their work, interact and receive feedback from experts, establish collaborations
and professional connections; 3) Promote participation in the conference by providing travel awards to students
and trainees for outstanding oral and poster presentations and travel funding assistance for invited speakers.
Scientific objectives of the 2024 meeting include: 1) Update the epidemiological landscape of the Vitamins B
deficiencies and their links to malabsorption, infectious and chronic diseases, such as obesity and diabetes. 2)
Evaluate evidence of the transgenerational impact of maternal/paternal OCM and B-vitamins status in peri- and
post-natal health: obesity, diabetes, neurological/psychiatric/developmental disorders. 3) Revise the science and
clinical practice in inherited metabolic disorders of B-vitamins and OCM for diagnosis, pathophysiology, and
treatment aspects. 4) Evaluate experimental- and population-based evidence of the crosstalk between Vitamins
B/OCM status and genomics/epigenomics in health and disease. 5) Discuss/compare utility of cell and animal
models in experimental studies of OCM/B-vitamins in health and diseases. 6) Update our knowledge on the B-
vitamins and OCM in cancer prevention, pathophysiology, and treatment. 7) Analyze the experimental- and
population-based evidence on the “two sides of the coin” issue with B-vitamins supplementation/fortification.
The above aims will be accomplished over 10 sessions including the invited speakers’ presentations and short
talks from select abstracts submitted by young scientists, two poster sessions (2 hours each), “meet the experts”
metabolomics workshop for trainees/young investigators, and a career-oriented workshop with young scientists
discussing research and professional development with session chairs in small groups. Opportunities for informal
interactions among attendees are frequent during the meals, breaks, poster sessions and outdoor recreational
activities. These direct personal interactions ensue new ideas, research directions/collaborations, promote
professional development of young investigators, and energize the future of the field.

Public health relevance
PROJECT NARRATIVE Our proposal requests partial funding of the 2024 FASEB SRC on “B-Vitamins and One-Carbon Metabolism in Health and Disease” scheduled to take place August 11-16, 2024, at Sheraton Niagara Falls/Niagara Falls Convention Center, in Niagara Falls, NY. The goals of the meeting are to convene world experts as well as trainees in the area of B-Vitamins and One-Carbon Metabolism to present and discuss the latest, cutting-edge research and its implications for Public Health. This conference provides important educational and networking opportunities for the young investigators and trainees attending the meeting, including the opportunity to present their own research.